Cancer Immunology and Immunotherapy Program

Cancer Immunology Program: Summary
The mission of the Cancer Immunology (CI) Program is to understand the molecular basis and dynamic
relationship between the immune system and cancer in order to translate this knowledge into novel and
improved therapeutics.
The CI Program has been restructured to focus on the pipeline from cancer immunology to immunotherapy,
with research spanning from basic mechanistic studies in mouse models to investigating the response of the
immune system in cancer patients receiving the latest immune-based therapeutics in the clinic. The CI
Program has been strengthened by the establishment of the HDFCCC Cancer Immunotherapy Research Clinic
in April 2016, allowing a more systematic evaluation of patients receiving immunotherapies as standard of care
or as part of prospective clinical trials. In doing so, the goal is to enhance the efficacy of these approaches, but
also to avoid the toxicities associated with the current generation of checkpoint blockade and CAR T cell-based
therapies. CI Program members have made significant new scientific findings in the field of cancer immunology,
particularly with respect to understanding the tumor microenvironment and basic mechanisms of interactions
between immune cells and tumors. Program members have recently made many important contributions to the
understanding of the interplay between the immune system and tumors, crossing each of the three themes.
Theme 1: Identifying Immune System Mechanisms that Regulate Cancer Initiation and Progression
Theme 2: Defining the Role of the Tumor Microenvironment in Cancer Immunity
Theme 3: Developing Novel Approaches to Cancer Immunotherapy and Understanding Mechanisms
Underlying their Efficacy and Toxicities
CI Program: Key Metrics
Membership (12 departments, 2 schools) 23
Full 17
Associate 6
Cancer-relevant Funding (direct costs as of
$24,118,432
05/31/2017)
NCI $4,117,666 17%
Peer-reviewed $6,463,606 27%
Non-peer-reviewed $13,537,159 56%
Cancer-relevant Publications (1/2012-7/2017) 419
Inter-programmatic 96 23%
Intra-Programmatic 38 9%
High-Impact 177 42%
Accruals to Clinical Trials (2016) 124
Therapeutic 124 30
Other Interventional 0 0
Non-interventional 0 0

In 2019-20, the HDFCCC developed a new strategic plan to guide decisions related to the research activities in the Center. The details of this strategic review process are discussed in the Leadership, Planning and Evaluation section of this report. Based on the research priorities identified in this plan, and with input from the EAB and the NCI, there have been changes to the structure of the CCSG-funded Research Programs to better support the evolving and innovative research of HDFCCC members. The new structure includes the merging of the previous Cancer Immunology Program and Hematopoietic Malignancies Program into a new Cancer Immunology and Immunotherapy Program, discussed here.

The Cancer Immunology and Immunotherapy Program (CII) now has four co-leaders, one Education and Training Liaison, and one Community Engagement Liaison. The descriptions of these latter roles are in the respective component sections of this report. The Cancer Immunology and Immunotherapy Program’s leadership roster is as follows: Lewis Lanier, PhD, Lawrence Fong, MD, Neil Shah, MD, PhD, Thomas Martin, MD: Program Co-Leaders; Nina Shah, MD: Education and Training Liaison; Bita Fakhri, MD, MPH: Community Engagement Liaison. In 2020, the CI Program added two new full members and five new associate members.

The clinical program will work with Kim Rhoads and the Office of Community Engagement to enhance visibility and engagement with underserved patients within our catchment area. We are also working with Terence Friedlander (MO) at Zuckerberg San Francisco General Hospital and have activated a protocol there assessing immune responses to cancer therapies.